Causes and consequences of regulatory genetic variation

Project Summary / Abstract
Genetic variation among individuals shapes important phenotypes, including the risk for common human
diseases. In particular, regulatory genetic variation causes inter-individual differences in gene expression.
The resulting gene expression differences account for a substantial portion of variation in many genetically
complex traits.
In spite of the critical importance of regulatory variation, many fundamental questions remain open. A
particularly critical open question is that we only have a crude understanding of how the differences in gene
expression that result from regulatory variation affect organismal phenotypes. This question is a key focus
of the research program funded by the parent award for this equipment supplement.
Under the parent award, research in my laboratory addresses these critical gaps in knowledge. Our work
combines computational biology, quantitative and statistical genetics with experimental genome-wide
approaches. We use the yeast Saccharomyces cerevisiae as a powerful and tractable model system for
regulatory variation.
This equipment supplement removes a critical roadblock in our research program. In our work, we construct
libraries of thousands of strains. This award will support the purchase of a high-throughput phenotyping
platform that will enable us to rigorously collect trait data from these strains. These data will allow us link
genotype and phenotype rapidly and with quantitative precision.
The requested instrument is in service of our long-term vision to improve our understanding of regulatory
variation to the point at which it becomes possible to accurately predict the consequences of the DNA
variants in an individual’s genome. This ability will be valuable for fundamental research and personalized
approaches for improving human health.

Public health relevance
Project Narrative This project will address fundamental questions about the causes, molecular mechanisms, and phenotypic consequences of regulatory genetic variation. Regulatory variation arises from inter-individual differences in DNA sequence that alter gene expression and underpin much of the genetic risk for common human diseases. A better understanding about the causes and consequences of regulatory variation will improve our ability to predict genetic disease risk from individual genomes.